Center for AIDS Research at Emory University

PROJECT SUMMARY/ABSTRACT
This application is to expand the Administrative Core of the Center for AIDS Research at Emory University
(Emory CFAR) to include the Adelante Research Capacity Program. Since first funding in 1997, the Emory
CFAR has risen to preeminence in the HIV research community, through the development and support of its
members. Emory CFAR Members possess broad expertise representing the full scientific spectrum needed to
accelerate HIV science from the bench to the bedside to the communities we serve. Emory CFAR
organizes this expertise into five research focus areas: Basic Research, Pre-Clinical Research, Clinical
Research, Prevention Science, and Public Health. These focus areas are served by an Administrative Core, a
Developmental Core, five Science Cores (Biostatistics and Bioinformatics; Clinical Research; Prevention and
Implementation Sciences; Systems Immunology; and Virology and Molecular Biomarkers); and two Scientific
Working Groups (SWGs) - Health Equity and Next Generation Therapeutics.
The Emory CFAR is uniquely poised—geographically and scientifically—to achieve our mission. We are
located at the epicenter of four high burden counties as defined by Phase I of the Ending the HIV Epidemic
Initiative. These metro-Atlanta counties are home to almost 3.5M persons (54% African American; 5.2%
Hispanic/Latinx), representing one-third of Georgia's population. Our location allows CFAR Members to apply
necessary scientific tools to achieve EHE goals and advance NIH research priorities. Given the high burden of
HIV in our geographical region, coupled with clear inequities in access to healthcare in the communities we
serve, the Emory CFAR is committed to working toward equity in all aspects of research, faculty
development, and community engagement. We will intentionally seek to recruit and develop a cadre of
URM investigators in collaboration with our colleagues at Morehouse School of Medicine, and we will continue
to elevate the role of the CFAR Community Liaison Council, expanding their influence within the CFAR to
guide best practice for the dissemination of HIV research findings and together, we will strive to build
community trust in research through the intentional inclusion of key stakeholders at all stages of the research
pipeline. The Emory CFAR proposes the following Specific Aims:
Aim 1. Advance groundbreaking HIV research across the entire scientific spectrum of NIH-defined
priority research areas to end the epidemic for all and to promote health equity.
Aim 2. Cultivate cutting-edge tools and services to support transdisciplinary research teams.
Aim 3. Develop and train the next generation of outstanding and diverse HIV investigators.
Aim 4. Elevate multidirectional community stakeholder engagement to improve the well-being of people
living with and at risk for HIV across their lifespan.

Public health relevance
PROJECT NARRATIVE The Emory CFAR will contribute to ending the HIV epidemic by accelerating the highest caliber translational research — fostering team science, equity, and multidirectional stakeholder engagement. We will strive to build community trust in research through the intentional inclusion of key stakeholders at all stages of the research pipeline. We will achieve our goals by providing innovative services, tools, expertise, and access to state-of- the-art equipment through an Administrative Core, including the Adelante Research Capacity Program, a Developmental Core, five Science Cores (Biostatistics and Bioinformatics; Clinical Research; Prevention and Implementation Sciences; Systems Immunology; and Virology and Molecular Biomarkers); and two Scientific Working Groups (SWGs) - Health Equity and Next Generation Therapeutics.